Microscopic Imaging

Project Summary Optical Imaging Core
The use of optical imaging to assay structure and function of the visual system at a variety of
length scales, from subcellular structures to living animal and human eyes, continues to expand.
Improved fluorescent probes and an expanding arsenal of new imaging technologies, make
optical techniques for measuring and manipulating cells and circuit function more powerful and
popular than ever. New scanners allowed for rapid volumetric imaging of tissue, new
optogenetic, and opto-pharmacology tallow for control of neural activity by light, new ways of
generating patterns of light (e.g., holography) allow optical stimulation and imaging in intact
tissue. For in vivo applications, adaptive optics and eye tracking facilitate the translation of
modern optical techniques into living animal and human eyes. We are fortunate to have gifted
optical imaging specialist, Ben Smith, who will continue to carry out the work of the Optical
Imaging Core, bringing these and other technologies to Vision Science labs throughout campus.
The Aims of this Core are 1) Leverage the existing expertise and instrumentation that is already
available on campus to bring more Vision Science investigators into the world of advanced
optical techniques, 2) Assist Core investigators in customizing their own imaging equipment to
best take advantage of new technologies, including the light-activated ion channels described
above. 3) Assist CORE investigators in assembling sophisticated imaging systems from
component parts, including confocal and 2-photon microscopes.

Public health relevance
Narrative Optical Imaging Core The Optical Imaging Core will serve the UC Berkeley Vision Science community by introducing and training investigators into the world of advanced optical techniques, assisting investigators in customizing their own imaging equipment for new uses, and assist investigators in assembling sophisticated imaging systems from component parts, including confocal and 2-photon microscopes.